Sample-specific Models for Molecular Portraits of Diseases in Precision Medicine

A fundamental challenge in precision medicine is to understand the patterns of differentiation between individuals. To
address this challenge, we propose to go beyond the traditional `one disease--one model' view of bioinformatics and
pursue a new view built upon personalized patient models that facilitates precision medicine by leveraging both
commonalities within a patient cohort as well as signatures unique to every individual patient. With the emergence of
large-scale databases such as The Cancer Genome Atlas (TCGA), the International Cancer Genome Consortium
(ICGC), and the Gene Expression Omnibus (GEO), which collect multi-omic data on many different diseases, a new
“pan-omics” and “pan-disease” paradigm has emerged to jointly analyze all patients in a disease cohort while
accounting for patient-specific effects. An example of this is the recently released Pan-Cancer Atlas. At the same time,
next generation statistical tools to accurately and rigorously draw the necessary inferences are lacking.
In this project we propose a series of mathematically rigorous, statistically sound, and computationally feasible
approaches to infer sample-specific models, providing a more complete view of heterogeneous datasets. By bringing
together ideas from the machine learning, statistics, and mathematical optimization communities, we provide a
rigorous framework for precision medicine via sample-specific statistical models. Crucially, we propose to analyze this
framework and prove strong theoretical guarantees under weak assumptions--this dramatically distinguishes our
framework from much of the existing literature. Towards these goals, we propose the following aims:
Aim 1: Discovery of new molecular profiles with sample-specific statistical models. We propose a general framework
for inferring sample-specific models with low-rank structure based on the novel concept of distance-matching. This
allows us to infer statistical models at the level of a single patient without overfitting, and is general enough to be
applied for prediction, classification, and network inference as well as a variety of diseases and phenotypes.
Aim 2: Multimodal approaches to personalized diagnosis--contextually interpretable models for actionable clinical
decision support. In order to translate these models into practice, we propose a novel interpretable predictive model
that supports complex, multimodal data types such as images and text combined with high-level interpretable features
such as SNP data, gender, age, etc. This framework simultaneously boosts the accuracy of clinical predictions by
exploiting sample heterogeneity while providing human-digestable explanations for the predictions being made.
Aim 3: Next-generation precision medicine--algorithms and software for personalized estimation. To put our models
into practical use, we will develop new algorithms for interpretable prediction of personalized clinical outcomes and
visualization of personalized statistical models. All of our tools will be combined into a user-friendly software package
called PrecisionX that will be freely available to researchers and clinicians everywhere.
RELEVANCE (See instructions):
Personalization with data is a critical challenge whenever decisions must be made at scale, and has applications that
go beyond precision medicine; businesses, educational institutions, and financial institutions are among the many
players that have acknowledged a stake in this complex problem. We expect the proposed work to provide a rigorous
foundation for personalization with large and high-dimensional datasets, finding use throughout the broader scientific
community as well as with industry and educational institutions. Alongside our collaboration with Pitt/UPMC, we will
work with physicians and data scientists for practical feedback as well as provide training in the methods developed.

Public health relevance
Personalization with data is a critical challenge whenever decisions must be made at scale, and has applications that go beyond precision medicine; businesses, educational institutions, and financial institutions are among the many players that have acknowledged a stake in this complex problem. We expect the proposed work to provide a rigorous foundation for personalization with large and high-dimensional datasets, finding use throughout the broader scientific community as well as with industry and educational institutions. Alongside our collaboration with Pitt/UPMC, we will work with physicians and data scientists for practical feedback as well as provide training in the methods developed.